ESTROGEN IN MYOCARDIAL PERFORMANCE IN POSTMENOPAUSAL FEMALES

The purpose of this project is to evaluate the effect of estrogen versus placebo on the myocardial performance of postmenopausal females who undergo Exercise Echocardiography.